MOLECULAR MODELLING: PROGRAM NAMD: MOLECULAR DYNAMICS

NAMD, the MD core of MDScope, is a parallel molecular dynamics program for simulations of large biological macro-molecularsystems. It is specifically designed for distributed memory parallel computers. It uses spatial decomposition and message-driven execution to exploit the computational power of these machines.Another major strength of NAMD is its modular and object-oriented design that allows researchers to develop and test various new algorithms and to easily incorporate other algorithms suchas the distributed parallel multipole tree algorithm (dpmta[44])for fast full electrostatic force calculations. The program has been significantly improved in recent months bythe addition of new features, including spherical boundary conditions, harmonic constraints, multiple-time-stepping schemes, andrigid bonds to hydrogen. More features such as hydrogen bonds,periodic boundary conditions, and constant pressure dynamics are currently being implemented. The performance has been enhanced by reducing communication costs and improving load balancing techniques. Currently, the program is being restructuredto further improve its performance and exploit newer parallel machines such as clusters of symmetric multiprocessor systems. As part of MDScope, NAMD is being used for interactive molecular dynamics. Molecular systems currently being studied includeprotein-DNA systems (37,000 atoms), bacteriorhodopsin (3,800 atoms), and the poliovirus capsid (30,000 atoms). Another public release of the program (NAMD 1.4) has been recently completed. The program and extensive documentation are available via anonymous ftp.Further information on NAMD isavailable at http//www.ks.uiuc.edu/Research/namd/.